Global Genomic and Proteomic Profiling of African Children with Typhoid Fever

DESCRIPTION (provided by applicant): Typhoid fever is caused by Salmonella enteric serovar Typhi (S. typhi), a human specific pathogen. The World Health Organization (WHO) recognizes typhoid fever as a global health problem, with an estimated 21 million cases and 200,000-600,000 deaths annually. In Africa and South Asia, young children represent a subgroup with the highest disease burden. The onset of the illness is insidious and clinical diagnosis is often unreliable. Definitive diagnosis through blood or bone-marrow culture is labor-intensive, expensive, and invasive, with a sensitivity of 40 to 70%. WHO recommends routine typhoid fever vaccination but currently licensed vaccines provide only 55-75% protection against the disease. Therefore, there is an urgent need to develop rapid, sensitive, and inexpensive diagnostic methods, as well as more efficacious vaccines for countries where typhoid fever remains a major public health burden. Our long term goals are 1) to develop innovative molecular diagnostic assays for rapid and inexpensive detection of typhoid fever and, 2) to better understand the molecular mechanisms of host response to facilitate the development of next-generation typhoid fever vaccines. Our immediate objective is to obtain global gene expression and proteomic profiles of S. typhi- infected African children, identify and validate the classifier genes and proteins as potential diagnostic biomarkers and vaccine targets. We have already established a bacteremia surveillance system in central Nigeria since 2008. A pilot study was initiated from a small cohort of Nigerian children with typhoid fever. Our preliminary data showed unique gene expression profiles of host response in peripheral blood of children with typhoid fever compared with other bacteremic infections, as well as patients in acute vs. convalescent phase. Here, we hypothesize that distinct classifier genes and proteins based on host response in the peripheral blood and serum can be obtained to discriminate typhoid fever from other bacteremic infections and healthy controls. Our specific aims are: 1) Define typhoid fever-specific host response classifier genes using gene expression (GE) microarrays, 2) Discover specific serum anti-typhoid fever proteins using newly established S. typhi proteome microarrays and develop prototype serologic assay for acute typhoid (ELISA) 3) Validate classifier genes and field-test prototype ELISAs using new, independent cohorts. To accomplish these objectives, we have assembled a multidisciplinary team with expertise in infectious disease, immunology, molecular genomics/proteomics, microarrays, and bioinformatics to ensure success of this project. These studies will identify distinct classifier genes and proteins f typhoid fever infection based on immunological responses. Classifiers that discriminate S. typhi from other bacteremia are possible to develop and offer rapid, inexpensive, non-invasive, and sensitive molecular diagnostic assays specific for typhoid fever. Classifier proteins obtained from our new, custom whole-proteome typhoid fever microarrays will provide new insights of targeted proteins and antibodies for next-generation vaccine development. PUBLIC HEALTH RELEVANCE: Disease control for typhoid fever has remained a global health challenge, although vaccines are available, protective efficacy is low and expensive diagnostic tests continue to confound the determination of the true burden of disease in poor-resource settings. Inexpensive, easy-to-use, and highly-sensitive diagnostic tests are currently unavailable. This project focuses on acquiring global gene expression and proteomic profiles and identifying classifiers genes and proteins in African children with typhoid fever to better understand their host response, which will lead us to our long term goals of developing better diagnostic tools and vaccines for typhoid fever to improve public health, especially of the African children.

Public health relevance
Disease control for typhoid fever has remained a global health challenge, although vaccines are available, protective efficacy is low and expensive diagnostic tests continue to confound the determination of the true burden of disease in poor-resource settings. Inexpensive, easy-to-use, and highly-sensitive diagnostic tests are currently unavailable. This project focuses on acquiring global gene expression and proteomic profiles and identifying classifiers genes and proteins in African children with typhoid fever to better understand their host response, which will lead us to our long term goals of developing better diagnostic tools and vaccines for typhoid fever to improve public health, especially of the African children.